Neuropharmacology Core

PROJECT SUMMARY/ABSTRACT
The Center of Research Excellence in Natural Products Neuroscience (CORE-NPN) at The University of
Mississippi School of Pharmacy (UM), initiated ten years ago through a COBRE grant, has developed a
multidisciplinary team committed to evaluating the effects of natural products on the central nervous system
(CNS). The Neuropharmacology Research Core of the COBRE CORE-NPN program represents a shared
resource serving biomedical investigators / users with specialized services and training in neuropharmacological
bioassays based on (a) competitive radioligand receptor binding, (b) modulation of molecular/biochemical target
functions (c) cell-based phenotypic & functional responses and (d) in vivo behavioral pharmacology. This was
originally two Cores, in vitro and in vivo pharmacology, in Phases I and II, with strong utilization by investigators
and strong collaboration between the two. In Phase III, it has been determined that these Cores would best serve
the program as one functional unit. Furthermore, by the end of Phase III, the Core is projected to be largely
sustainable with efforts focused on understanding neuropharmacological properties of lead biological extracts or
purified compounds and how they interact with biological systems. Efforts have been focused on expanding the
core capabilities by increasing both in vitro and in vivo assays that are available to users, thereby increasing the
numbers of projected users served. A fee-for-service/chargeback business model will be implemented during
Phase III to ensure sustainability post Phase III. Specific Core services include radioligand binding and functional
assays for cannabinoid, opioid, and Neuropeptide FF G protein-coupled receptors (GPCRs), as well as enzyme
assays, phenotypic neuronal cell cultures-based assays, and analysis of neuropharmacological signaling
pathways. Moreover, the Core offers a battery of acute behavioral rodent and zebrafish assays to evaluate
natural product extracts and purified compounds in vivo. New in vitro assays and animal models will continue to
be developed to support user needs, which ultimately broadens the overall scope and user-base for the Core.
The Core is positioned to become a leader in neuropharmacological services based on natural product and
synthetic drug development campaigns. We plan to achieve this through the following Specific Aims: 1) To
enhance the research of the COBRE CORE-NPN and the associated community through state-of-the-art
equipment, cutting-edge techniques, and scientific expertise; 2) To advance an infrastructure of developmental
services to facilitate COBRE CORE-NPN research and the associated community by continual refinement and
addition of assays through user input. 3) To accelerate a long-term plan for sustainability of the Core through
expansion of the user base, integration of a fee-for-service structure, institutional support, and adaptation to
changes by monitoring the needs of the users.